ADRENOLEUKODYSTROPHY--STUDIES OF FEMALE HETEROZYGOTES

This project attempts to delineate the nature, frequency, and natural history of clinical manifestations among women heterozygotes for adrenoleukodystrophy.